Targeting the NLRP3 Inflammasome to Mitigate Neuroinflammation and HIV Persistence in the CNS: Mechanisms and Therapeutic Strategies

PROJECT SUMMARY
Even with effective antiretroviral therapy (ART) that suppresses viral replication, individuals with HIV frequently
experience chronic neuroinflammation and immune activation, leading to increased risk of neurocognitive
disorders and other health complications. The connection between persistent HIV reservoirs in the central
nervous system (CNS) and ongoing neuroinflammation remains poorly understood. This project investigates the
role of the NLRP3 inflammasome in HIV-induced neuroinflammation, with a particular focus on how
inflammasome activation contributes to blood-brain barrier (BBB) dysfunction and the persistence of HIV latency
in the CNS. The research team, with expertise spanning HIV biology, inflammasome pathways, CNS model
systems, and advanced data analysis, is uniquely equipped to address this critical gap in knowledge. Aim 1: This
aim seeks to elucidate the link between HIV-1 infection and NLRP3 inflammasome activation in the CNS. We
will use advanced brain organoid models and humanized mouse models to study how HIV-1 triggers
inflammasome activation in microglia and contributes to BBB breakdown, providing insights into the mechanisms
that sustain neuroinflammation and HIV persistence. Aim 2: This aim investigates the impact of NLRP3
inflammasome activation on the establishment and maintenance of HIV latency in the CNS. By examining how
inflammasome activation influences the behavior of latent HIV reservoirs, the study will explore potential
pathways that could be targeted to disrupt latency and reduce inflammation. Aim 3: This aim focuses on
developing and evaluating therapeutic strategies to mitigate neuroinflammation and HIV persistence. Using
innovative lineage tracing techniques and advanced in vivo models, we will test small molecule inhibitors and
other therapeutic interventions to assess their efficacy in reducing inflammasome-driven inflammation and
preserving CNS function. This project is expected to yield significant advancements in understanding the
mechanisms driving HIV-associated neuroinflammation and latency. The findings from this project will provide
crucial insights into the role of the NLRP3 inflammasome in sustaining HIV persistence, identify novel therapeutic
targets, and potentially pave the way for a functional cure for HIV, ultimately leading to improved treatment
strategies and quality of life for people living with HIV.

Public health relevance
PROJECT NARRATIVE This project investigates the role of the NLRP3 inflammasome in HIV-1-associated neuroinflammation and its impact on the persistence of viral reservoirs within the central nervous system (CNS). By focusing on how HIV- 1 triggers inflammasome activation in microglia and contributes to blood-brain barrier (BBB) dysfunction, we aim to uncover the molecular pathways that sustain HIV persistence and drive neuroinflammation. Utilizing advanced brain organoid models, humanized mouse models, and innovative lineage tracing techniques, our goal is to identify novel therapeutic targets that can mitigate chronic inflammation, disrupt HIV latency, and pave the way for the development of a functional cure for HIV.